Deciphering the Principles of Membrane-Associated Glycan Assembly for Glycoconjugate Biosynthesis

Metabolons are non-covalent complexes of enzymes that play crucial roles in primary and secondary
metabolism. Such supramolecular complexes carry out a series of reactions in a pathway while protecting
intermediates from diffusion into the bulk phase and promoting product channeling. This mechanism increases
reaction efficiency and fidelity and protects labile intermediates. Although there has been tremendous progress
in understanding the structures and functions of soluble metabolons, the study of membrane-associated
metabolons is complicated by the extra dimensions added by membrane and lipidic substrates. A membrane-
associated metabolon of significance is the eukaryotic dolichol pathway in which the dolichol diphosphate-linked
glycan for asparagine (N)-linked of glycosylation is assembled. Bacterial glycoproteins in the epsilon
proteobacteria including Campylobacter, are also generated through stepwise, membrane-associated
pathways and culminate in the biosynthesis of important virulence-associated glycoproteins. Study of the
bacterial pathway and extensive genomic information from Campylobacter, providing data on the enzymes and
substrates in vivo across >50 discrete genera, adds a important dimension to our studies as operon order is
highly conserved but, glycan output varies and there is considerable sequence divergence. Development of
systematic approaches for investigating the pgl pathways will provide a valuable template for future studies on
important multistep biological processes occurring at the membrane.
Despite the importance of such pathways, our understanding of how the enzymes function, and whether as
a metabolon or in a distributed fashion with diffusion of substrates/products between enzymes is limited. It is
also unknown how the GT-B fold, common to most pgl glycosyltransferases (GTs) leads to function and substrate
selectivity, as the similarity of active-site residues does not lead to a clear structure/function view, or account for
the impact of the interaction of enzymes or substrates with the membrane. The research has three aims. In Aim
1, PglA, J, H1 and H2 from the C. concisus glycan assembly metabolon will be investigated via X-ray structure
determination of complexes with UDP-sugar and PrenPP-sugar substrates, ligand binding and kinetic analysis,
MD simulations and membrane association determination in model membrane (styrene maleic acid
lipoparticles). In Aim 2, we will predict and validate protein-protein and protein-membrane interactions, determine
the effect of protein-protein interactions on pathway flux and test for product channeling. Aim 3 will generate
sequence similarity networks and genome neighborhood diagrams to identify orthologs in divergent species to
identify structural elements governing membrane and membrane-bound substrate interactions. We will also
investigate why a GT-A fold (GT) is recruited to perform the ultimate biosynthetic step.
If successful, the research will provide a newly proposed paradigm for specificity established by membrane
interactions and the approaches to enable study of other membrane-resident biosynthesis pathways.

Public health relevance
Biological membranes are self-assembled molecular walls that are found within and around the cells of all living organisms. Rather than serving simply as barriers to establish boundaries however, these essential dynamic structures provide a unique environment for organizing steps in biological pathways. This work will elucidate whether proteins in membrane- associated pathways that elaborate sugar structures perform their function, as isolated entities or as collaborative teams. Ultimately this work will provide insight into fundamental biological processes including bacterial infection.